Assessing the Interrelationship Between Adipose Tissue Thermogenesis and Fibrosis in the Metabolic Health of People Living with HIV

PROJECT SUMMARY/ABSTRACT
Insulin resistance is a key driver of type 2 diabetes (T2D). Interestingly, people living with HIV (PLWH) are prone
to developing insulin resistance and T2D, even with viral suppression. In determining what drives this insulin
resistance, we have focused on the fact that whereas obesity is a common trait in humans, T2D risk is increased
by “metabolically unhealthy obesity” (MUO). Emerging observations point to two factors promoting MUO in the
general population: 1) reduced mitochondrial content and fewer mitochondria-enriched “beige” adipocytes in the
subcutaneous fat (SCAT) and 2) Development of SCAT fibrosis. Moreover, reducing beige fat biogenesis in mice
promotes SCAT fibrosis and insulin resistance, whereas increasing it remarkably blocks fibrosis and improves
insulin sensitivity. With this in mind, we and others have observd that PLWH have markedly increased SCAT
fibrosis, a response replicated in SIV-infected macaques. This prompts us to wonder whether PLWH also have
suppressed beige adipocyte biogenesis, and what factors dictate this. To this end, we recently identified a subset
of adipogenic precursor cells (APCs) expressing signature markers (Lin–: PDGFRa+: CD81+) that control a
reciprocal balance between beige fat biogenesis and SCAT fibrosis. Specifically, CD81+ APCs give rise to
mitochondria-rich beige adipocytes in the SCAT, whereas CD81 deficiency causes both SCAT fibrosis and
insulin resistance in mice. These data highlight the intriguing possibility that CD81+ APCs in the SCAT may
influence development of MUO in PLWH. We also reported that beige/brown fat is a metabolic sink for branched-
chain amino acids (BCAAs), the circulating levels of which are linked to human insulin resistance. Activating
brown/beige fat biogenesis clears circulating BCAAs in humans; indeed, BCAA clearance is a noninvasive
indicator of brown/beige fat activity. However, the impact of BCAA usage in fat has not been assessed in PLWH.
We hypothesize that a reduced capacity of CD81+ APCs to maintain normal SCAT function, reflected by SCAT
fibrosis and impaired BCAA clearance, drives insulin resistance in PLWH, and that reversing this may improve
metabolic health. Leveraging an innovative cohort of PLWH and uninfected controls, including those with MUO,
we propose to test this hypothesis by pursuing two aims, each integrating a comprehensive human study with
mechanistic studies in innovative mouse models. In Aim 1, we examine the extent to which loss of CD81+ APC
abundance, proliferative capacity, or differentiation potential predicts SCAT fibrosis and insulin resistance in
PLWH, and whether manipulating these cells can modulate SCAT fibrosis in mice. In Aim 2, we probe adipose
clearance of BCAAs as a determinant of glucose homeostasis in PLWH, and determine the impact of disrupting
beige/brown fat BCAA usage on SAT fibrosis and metabolic health in mice. By validating a mechanistic index of
SCAT health (CD81+ APCs, fibrosis, BCAA clearance) that predicts MUO, and leveraging this index to improve
insulin sensitivity, we may be able to reveals new ways to prolong the metabolic healthspan of PLWH.

Public health relevance
PROJECT NARRATIVE Metabolically active fat cells rich in mitochondria (called “brown” or “beige”) maintain normal insulin sensitivity in healthy individuals, but their ability to do so is progressively diminished with obesity and advancing age, leading the fat tissue to undergo a process called fibrosis that is closely linked to insulin resistance and type 2 diabetes. Despite the effectiveness of medications combating HIV, and the consequent reduction in the prevalence of AIDS, people living with HIV (PLWH) also develop insulin resistance and diabetes at high rates, and recent work, including from our group, shows that this process is associated profound fat fibrosis. We have developed highly innovative tools to monitor and manipulate beige-specific fat cells, and propose to use these to determine the extent to which beige fat cells are able to both mark the fibrotic process by which PLWH develop insulin resistance, and to serve as a potential avenue to intervene in this process in order to improve metabolic health for PLWH.